42nd International Symposium on Halogenated persistent Organic Pollutants, Dioxin 2022

PROJECT SUMMARY/ABSTRACT
The 42nd International Symposium on Halogenated Persistent Organic Pollutants (POPs), DIOXIN 2022, will be
held from October 9-14 2022 in New Orleans, Louisiana, USA at the Sheraton Hotel New Orleans o Canal Street.
This will be a return of annual DIOXIN meeting to USA after 12 years (previously held in 2010 in San Antonio,
Texas)
Dioxin meeting has been founded to address the urgent research needs due to environmental pollution and
health effect associated with the polychlorinated dibenzo-p-dioxins and polychlorinated dibenzo furans, as well
as other halogenated persistent pollutants named in the Stockholm Convention. Over its 42 years history, the
Symposium has evolved to into one of the most prestigious conferences that discusses most important and
current environmental issues associated with halogenated organic pollutants and their impact on environment
and human health, the methods for detection of both parent pollutants and their environmental transformation
products and the methods for their removal and abatement and environmental release prevention. The meeting
locations are carefully selected by the International Advisory Board (IAB) of the Symposium based on the
submitted applications to ensure global reach of the meeting and uniform representation of meeting locations
from all regions of the world.
The 42nd Symposium program will emphasize the interdisciplinary nature of the persistent organic pollutants
(POPs) problems. We are planning to invite a world renown and leading scientists to deliver plenary lectures. To
enhance the participation of potential attendees and stimulate the vigorous discussions. A vibrant scientific
program will cover a broad range of topics associated with the (POPs) – besides discussions on pollutants
associated with the superfund sites, we are also including in the program new topics, that are representing the
most current and emerging pollutants such as for example perfluorinated compounds, nano and microplastics,
environmentally persistent free radicals (EPFRs). The meeting includes representation of the variety of science
and engineering disciplines, from remediation strategies, policy, emission limitations, through environmental and
health impact to epidemiology and environmental fate. This meeting has a format of an open public forum for
presentations of most recent advances and developments in the scientific research on a broad range of issues
related to the release and environmental presence of halogenated persistent organic pollutants named in the
Stockholm convention as well as new and emerging contaminants. It also provides an excellent training
opportunity for students and trainees, where young scientists have an opportunity to meet face-to-face, exchange
ideas and engage in discussions with more experienced researchers.

Public health relevance
NARRATIVE The 42nd International Symposium on Halogenated Persistent Organic Pollutants, Dioxin 2022, will continue as the leading international conference for scientists and regulators to present recent advances in all areas related to halogenated persistent organic pollutants and related ecological, environmental and human health effects. The high quality scientific program for Dioxin 2022 combining both traditional topics and emerging issues, will provide a unique interdisciplinary forum and numerous opportunities for delegates from all over the world to exchange new ideas face-to-face and to establish future international scientific and research collaborations on these contaminants of global concern.